Administrative Core (AC)

PROJECT SUMMARY - ADMINISTRATIVE CORE
The Administrative Core (AC) will provide a structure to facilitate effective and collaborative interactions between
the TCORS team. The AC will ensure all programmatic activities focus on achieving the overall goal of the Center
– using our theme, “Flipping the Script”: Using the Industry’s Nicotine Playbook to Maximize Public Health,
to understand how industry nicotine manipulations in electronic cigarettes (ECs) and oral nicotine pouches
(ONPs) are impacting product appeal, addictiveness, use patterns, and toxicity. The resulting data will inform
effective product standards and marketing regulations on nicotine manipulations with the intent to dissuade
young people, including non-users, from using ECs and ONPs, but still provide a satisfying and less harmful
alternative for adult tobacco users (smokers and smokeless tobacco users) who completely switch to these
products. The AC will foster and promote the goals of each component (cores and projects) by providing scientific
direction, administrative support, oversight, and coordination of Center activities to ensure operational efficiency.
The Specific Aims of the AC are to: 1) Provide overall research direction and center oversight by setting the
research agenda focused on determining how manipulation of nicotine and aspects of product packaging, impact
product appeal, addictiveness, and toxicity; 2) Promote communication and collaboration within the Center as
well as promote interaction between other funded TCORS, the Center for Coordination of Analysis, Science,
Enhancement, and Logistics (CASEL), the Center for Rapid Surveillance of Tobacco (CRST), and the FDA and
NIH staff; 3) Coordinate and organize committee structure and communications, and ensure operational
efficiency for all projects, pilot studies and cores of the center; and 4) Foster dissemination of tobacco regulatory
research findings, including data sharing. For this last aim, the Translational Tobacco Policy Team (TPT) will
have oversight and provide critical input ensuring research data has translational impact to inform effective
tobacco policy. The AC will ensure that all components of the Center work seamlessly together to accomplish
the overall and component-specific goals of this Center. The resulting data from our center projects will inform
effective product standards and marketing regulations on nicotine dimensions that dissuade young non-users
from using ECs and ONPs but still provide a satisfying and less harmful alternative for adult tobacco users.

Public health relevance
The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.